Nonclinical Development of an Improved Polio Vaccine

Abstract
In an SBIR Phase II, we developed an improved polio vaccine candidate, primarily for use
in the post-eradication era. We call the candidate, ultraIPVTM, because it is produced using a UVC-
inactivation method. UltraIPVTM has major improvements compared to existing IPV products,
such as IPOL (Sanofi) and VeroPol (Staten Serum Institute). The ultraIPVTM technology is
compatible with attenuated virus strains which reduce biosafety and biosecurity concerns during
manufacturing. The method is rapid and simple; only 30 seconds of UVC exposure is required for
inactivation. The UVC-inactivation process causes less amino acid degradation in protective
epitopes, which results in more vaccine units per milligram of virus allowing more doses per batch
with reduced costs per dose. Finally, the product is stable through multiple freeze-thaw cycles,
which bodes well for long-term storage in national stockpiles. In this SBIR Phase IIB, we propose
to complete critical non-clinical development activities for the trivalent ultraIPVTM. These
activities include manufacturing scale-up, GLP animal studies of safety and immunogenicity, and
IND application submission to prepare for clinical trials. We have assembled a team of subject
matter experts with the necessary experience to advance ultraIPVTM through the IND process and
beyond. For this product, we have several development avenues ready post-IND, including early-
stage interest from potential licensees.

Public health relevance
Narrative Because of safety concerns surrounding the reversion of pathogenic phenotypes with the use of the oral poliovirus vaccine (OPV), WHO and other agencies recommend that inactivated poliovirus vaccines (IPV) be used in the final stages of global eradication and for post-eradication vaccinations. IPV is produced by inactivating purified virus by prolonged incubations with formalin which reduces the immunogenicity and leads to a relatively high price per dose compared with OPV. In an SBIR Phase II funded by NIAID, we developed an improved polio vaccine that is safer to the population than OPV and safer and less costly to manufacture than IPV. The vaccine, ultraIPVTM, is killed using a novel UVC-inactivation process that is quick, reproducible, and produces more doses per milligram of virus than formalin inactivation. In this application, we propose to perform key IND-enabling studies to increase the value and attractiveness of the vaccine. Our long-term goals are to obtain IND approval, complete a Phase I clinical trial, and then out-license ultraIPVTM to a manufacturing partner. In this project, we will produce near- GMP vaccine material at a contract lab for safety and immunogenicity testing in GLP animal studies and prepare documents for IND approval to start clinical trials.